Understanding the effect of aging on the lung adenocarcinoma tumor microenvironment

PROJECT SUMMARY
Advances in immune checkpoint inhibition (ICI) therapies have shown great promise in activating lung
adenocarcinoma (LUAD) patients’ own anti-tumor immunity and prolonging survival. However, such
immunotherapies have shown variability in response among LUAD patients of different ages. With the
increasing age of lung cancer patients at diagnosis (35% are >75), there is a critical need for better
understanding of the relationship between age and the LUAD tumor microenvironment (TME). New insight into
the age-related cellular and molecular mechanisms and pathways in LUAD have the potential to uncover new
therapeutic opportunities to modulate the TME, synergize with existing therapies, and improve disease
outcome in elderly patients. We propose to use highly-parallelized single-cell RNA-sequencing (scRNA-seq)
and emerging single-cell resolution spatial technologies to characterize the effect of age on the LUAD TME.
We will integrate the scRNA-seq data collected as part of the Human Tumor Atlas Network (HTAN) with
publicly available data to increase our cohort size to ≥178 LUAD patients. The expanded scRNA-seq data set
will provide us with the necessary statistical power to decipher the cell type expression, cell composition, and
regulatory differences between LUAD patients of different ages. We will also use machine learning to model
the effect of cell type specific gene and pathway expression on TME cell compostion and search for
therapeutic targets across the integrated cohort in order to better understand the underlying
immunomodulatory mechanisms in the LUAD TME and how they associate with age. Finally, we will validate
our computational modeling by measuring the spatial organization of the TME using tissue samples from LUAD
patients of different ages. Our study promises to improve our understanding of the effect of age on cell-cell
interactions, gene expression programs, and multicellular communities in the TME, identify new treatment
strategies, and uncover new biomarkers that can improve therapy decisions for elderly LUAD patients. Finally,
our general methodology can be extended to study the relationship between age and the TME in other tumor
types in order to discover new age-specific therapeutic targets and improve patient stratification for treatment
in different disease contexts.

Public health relevance
PROJECT NARRATIVE This proposal seeks to better understand how using single-cell age organization programs, c therapeutic used age affects he tumor microenvironment in lung adenocarcinoma patient samples, which has primarily been studied in mouse models t o date and without the use of resolution sequencing technologies. Our approach will combine single-cell transcriptomic data and information from more than 178 patients with spatially-resolved measurements of tumor tissue and advanced computational modeling to uncover and validate age-specific gene expression ell-cell interactions, and spatially resolved multicellular communities that will rovide insight on new targets and improve stratification of treatment in elderly patients. Our general methodology can be to study the relationship between age and the immune microenvironment in other tumor types. t p